Structural and functional studies of M. tuberculosis type VII secretion

Dr. Oren Rosenberg is an infectious disease physician with a background in structural biology. His objective in this current project is to combine his clinical and basic science interests by studying the structure and function of key virulence determinants in Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis. Through a series of specific aims that use a combined structural, biochemical and genetic approach, Dr. Rosenberg will examine the role of essential components in the type VII secretion system, which is known to be critical for the virulence of Mtb. The goal is to understand mycobacterial infection better so as to aid in the design of faster, cheaper, less toxic and more effective ways to prevent and treat tuberculosis. Additionally this proposal is designed to complement Dr. Rosenberg's prior laboratory experience and provide him with the requisite technical and intellectual background in microbial pathogenesis and structural biology to function as an independent investigator. A committee of physicians and scientists will oversee Dr. Rosenberg's progression towards independence. His scientific development will also be enriched through attendance at UCSF courses in pertinent topics, several seminar series, departmental retreats and national meetings. Dr. Rosenberg will develop a clinical specialization in tuberculosis and other respiratory infections through work at the tuberculosis clinic at San Francisco General Hospital. At the end of the granting period Dr. Rosenberg will be prepared to develop his own research and clinical agenda as an independent investigator in the basic biology of microbial pathogenesis.

Public health relevance
PROJECT NARRATIVE: Tuberculosis is a global problem leading to over 1.7 million deaths each year. The proposed work is relevant to determining how the bacteria that cause tuberculosis are able to establish and maintain infection in a human host. Understanding this process at an atomic level will help us to design targeted therapies and vaccines. __SpecificAimsTextDelimiter__ 10. Specific Aims: Structural and functional studies of M. tuberculosis type VII secretion The ESX-1 Type VII secretion (T7S) system is required for the virulence of Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis. T7S systems are highly conserved throughout gram-positive bacteria, but not gram-negative bacteria or higher organisms The common components found in all T7S systems are a four-domain, ~130 KDa ATPase (EccC) and the ~10 KDa ESAT-6 family substrate proteins. The EccC ATPase is essential for the function of this system, yet very little is known about the mechanistic role this protein plays in secretion of T7S substrates. My goal is to use structural, biochemical and genetic techniques to elucidate the molecular mechanism of EccC in T7S. A detailed understanding of this key protein is essential to develop new therapeutics to either block ESX-1 secretion or utilize the system to engineer new vaccines. Specific Aim 1: Investigate the structure of the EccC ATPase as it moves through its cycle of Substrate Dependent Activation (SDA) My hypothesis is that the EccC domains drive secretion by moving through a series of conformational changes in a coordinated fashion. These changes require both nucleotide and protein-substrate. I base this hypothesis on three lines of evidence. First, foundational work by the Cox lab has shown that the EccC protein directly interacts with ESAT6-CFP-10 and that EccC is absolutely required for secretion. Second, my preliminary results show that the EccC ATPase is stimulated by addition of substrates. Third my preliminary electron microscopy (EM) studies show dramatic structural rearrangements with addition of nucleotide and substrate. Thus EccC binds to and is activated by the secreted T7S protein-substrates though we do not know the details of this interaction. I call this property of EccC "Substrate Dependant Activation (SDA)", meaning that the substrate is required for energy expenditure by the enzyme. The experiments in this aim will characterize the resting structure of EccC and the structural changes that accompany SDA. The Mtb EccC genes have resisted heterologous expression in E.coli and so I have cloned and expressed EccC from a series of different bacteria in order to find a homolog that is well-expressed and soluble. I have found two such EccC homologs from thermophilic bacteria that are suitable for structural and biochemical studies. I have obtained preliminary crystals of one of the EccC proteins and am now working to optimize these for diffraction studies. These proteins, which include the whole cytoplasmic domain of EccC (~90% of the protein) both form a unique, rigid, linear shape in our EM studies, and yet can transition to strikingly different structural forms with the addition of nucleotide or nucleotide analog. In combination with the studies in Aim 2, we will define the conditions under which these transitions occur and attempt to trap these different states for structural studies using nucleotide analogues and mutants. Specific Aim 2: Examine the relationship between ATP binding, hydrolysis and release by EccC and protein-substrate binding by EccC In this aim I lay out three models for how EccC might be interacting with its substrates to facilitate secretion. I propose to construct a series of mutants, which I will test for protein-substrate dependant activation and protein-substrate binding. Experimentally, I will use an ATPase assay I have piloted as well as a fluorescence binding-assay I will develop. The experiments are made possible by my ability to produce large quantities of heterologously expressed, full-length cytoplasmic EccC, as well as the protein-substrates for secretion, and easily make mutations and truncations to test my models. A second goal of these experiments is to discover EccC mutants that appear "trapped" at one stage in the ATPase cycle. Such intermediates may be homogeneous populations of EccC that can be analyzed by EM and crystallography. Specific Aim 3: Examine the role of each element of the EccC protein in T7S in living mycobacteria In this Aim I examine the role of the Mtb EccC protein in vivo. My hypothesis is that proper function of each of the individual elements of EccC is required for secretion of ESAT-6 and CFP-10 by the T7S system. I develop here a genetic approach to take the findings of Aim 1 and Aim 2 into living, virulent mycobacteria and eventually test detailed models about secretion in a medically relevant context. In my preliminary work, I have created an in-frame knock-out strain of Mtb deficient in EccC. I have produced a series of integrating complementation plasmids that each recapitulate part, but not all, of the functional domains of the EccC proteins. I now plan to put these plasmids into my knockout strain to test which domains of EccC are required for secretion of ESAT-6:CFP-10. As mutants are characterized by the studies in Aim 1 and Aim 2 we will be able to use this genetic system to study the relevance of the findings to ESX-1 secretion in the virulent organism. Eventually I hope to use resources now available in the Cox lab BSL3 facility to follow secretion and secretion mutants with live-cell imaging. We also have the capacity to take our findings into macrophage or mouse infections.